Low Neurophysiologic Resistance to Anesthetics as a Marker of Preclinical/Prodromal Alzheimer's Disease and Neurovascular Pathology, Delirium risk and Inattention

SUMMARY
In the parent R01 research project entitled "Low Neurophysiologic Resistance to Anesthetics as a Marker of
Preclinical/Prodromal Alzheimer's Disease and Neurovascular Pathology, Delirium risk and Inattention," we are
examining whether - neurodegenerative disease-type changes in brain
structure and activity, predispose patients to show altered brain activity changes in response to anesthetic drugs
provided during surgery. This R01 project exploits the idea that altered brain activity in response to anesthetic
drugs reflects an unhealthy brain, which may have latent signs of pre-clinical AD and which may indicate an
increased risk of POD. The expected outcome of the R01 project is to understand better the mechanisms
underlying intraoperative brain EEG responses to anesthetic drugs, postoperative delirium, Alzheimer s Disease
and related dementias, and relationships between these entities.
In this Administrative Supplement application, we propose to investigate the relationship between preclinical/
prodromal Lewy body dementia (LBD) pathology (ie altered forms of a protein called alpha synuclein)
. It has been well established that patients with delirium and
dementia display similar EEG abnormalities in pre-alpha/theta frequencies and dominant frequency overall,
similar to patients with LBD. Thus, EEG activity patterns during anesthesia may be able to serve as an
indicator -Synuclein levels, which might help to identify at risk patients for further workup for LBD, AD,
and other related dementias.2-4

Public health relevance
PROJECT NARRATIVE RT-QuIC is a technique that can detect α-Synuclein seeding activity with an overall sensitivity of 95.3% and 98% specificity in CSF samples. This technique will be used to determine levels of aggregated α-Synuclein in CSF samples from older adults undergoing non-cardiac surgery, who may have pro-dromal/latent lewy body pathology. The new data will be correlated with anesthetic dose adjusted EEG data from the parent R01 data to determine the effects of surgery with anesthesia in patients with LBD pathology, including altered anesthetic induced EEG waveforms and an increased risk of developing postoperative delirium (POD).